Scaling a Parenting EBI for Latinx Youth Mental Health in Primary Care

Project Summary
The prevention of adolescent mental health disorders is an underused but scientifically justified approach to
improving the public’s mental health. Youth with mental health disorders before the age of 18 have poorer
outcomes in education, social, employment, and health compared with youth without mental health or
substance use disorders. Hispanic youth report higher rates of depressive and anxiety symptoms, drug use,
suicide ideation and attempts, compared to their non-Hispanic White peers. Interventions designed to interrupt
the sequelae of mental health disorders and other poor outcomes are imperative for maximizing health among
Hispanic youth. Familias Unidas, which was highlighted in the National Academies of Sciences, Engineering,
and Medicine prevention report, has been found to be efficacious and effective in the reduction and/or
prevention of adolescent health problems. Familas Unidas has had crossover effects on internalizing
symptoms for youth who report low family communication, the intervention’s primary mediational pathway. It
has also reduced suicide ideation rates for youth reporting this same mediational pathway of poor family
communication. The online adaptation of Familias Unidas, eHealth Familias Unidas, has also been found to
reduce adolescent health problems. However, to date, evidence-based preventive interventions such as
Familias Unidas and eHealth Familias Unidas have largely been tested in schools and delivered mostly by
research staff. Evaluating these interventions in real world studies of primary care and understanding the
implementation processes that facilitate or impede the integration of interventions in systems is key to
improving mental health and reducing disparities in the U.S. The goal of the proposed application is to evaluate
in an effectiveness-implementation type I hybrid trial, an enhanced version of eHealth Familias Unidas for
reducing depressive and anxious symptoms as well as suicide behavior in Hispanic youth. Using a randomized
rollout design of 18 clinics, the study’s aims are: AIM 1: Evaluate the effectiveness of eHealth Familias Unidas
for Mental Health in preventing/reducing depressive, anxiety symptoms, suicide ideation and behavior, and
drug misuse among those screened as having poor family communication or elevated levels of depressive or
anxiety symptoms, or a history of suicide behavior (ideation or attempts); AIM 2: Determine whether
intervention effects are partially mediated by family communication and externalizing behaviors, including drug
misuse, and moderated by parental depression; and Exploratory AIM 3: Intervention impact on mental health
and drug misuse as well as sustainment will vary by quality of implementation at the levels of clinic and
clinician. Participants will be assed at baseline, 3, 6, and 18-months post baseline.

Public health relevance
PROJECT NARRATIVE This study will evaluate the effectiveness of an online adaptation of a parenting program delivered in primary care for Hispanic youth in preventing/reducing depressive and anxiety symptoms as well as in reducing suicide behavior. It will also examine the factors that facilitate or impede the integration of this parenting program in primary care. The knowledge expected to be gained in this study has the potential to transform the way prevention programs aimed at promoting mental health are delivered in primary care settings.